Development of a novel sensor for the real-time measurement of mitral coaptation force

Project Summary
The proposed project will develop a breakthrough endovascular sensor technology to allow for real-time
quantification of the mitral coaptation force (MCF) of the mitral valve during both open and percutaneous mitral
valve repair (MVR). Mitral regurgitation (MR) is the most common heart valve disorder in the U.S. population,
with over 2 million individuals affected. Current methods to assess MVR completion during surgery are lacking,
resulting in up to 25% of patients developing recurrent MR following surgery. New technologies must be
developed to allow surgeons to assess MCF during surgery in order to improve MVR and long term outcomes.
The proposed device, MitralPrint, is an endovascular guidewire with printed piezoelectric sensors on its distal
tip. It is designed to be inserted within the leaflets of the mitral valve to measure MCF in real-time. This innovative
device will allow surgeons to identify repair issues and confirm the successful completion of MVR, which
ultimately improves long term outcomes for patients by reducing MR recurrence. This device builds upon a
substantial amount of work already conducted by the MitralPrint team, including a USPTO/PCT provisional
patent, and ex vivo testing within a porcine heart.
The project will involve iterative prototype development, ultimately leading to an engineering freeze of the device
design, throughout the timeline of the proposal. This process will be informed through 1) benchtop testing to
validate sensor function and device useability, 2) ex vivo testing in a heart simulator to assess the feasibility of
acquiring MCF data in a porcine mitral valve and using this data to judge MR status, and 3) in vivo safety and
feasibility testing in a live animal porcine model, including determining the range of “healthy” MCF.
This project represents an innovative solution to a clear clinical need. The team represents all key aspects
required to ensure success of the project: medical device development, sensor engineering proficiency, and
cardiovascular surgical expertise. The approach is feasible within the anticipated timeline and budget, and is de-
risked through prior work and seasoned advisors.

Public health relevance
Project Narrative This project will result in the development of a novel endovascular sensing guidewire to quantify the mitral valve coaptation force (MCF) in real-time during mitral valve repair (MVR). This is a substantial unmet clinical need, with over 25% of patients who undergo MVR surgery having poor outcomes. Measuring MCF in real-time during MVR will allow surgeons to identify repair issues and improve patient outcomes.